Procession to IND of a capsid mutated AAV8 codon optimized NAGLU vector for treatment of Sanfilippo Syndrome type B (Supplement)

Project Summary
This supplement will enable the continued progress of the parent project to develop an AAV gene therapy
product for the treatment of mucopolysaccharidosis type IIIB, a disease for which there is no current
treatment. Specifically, this supplement performs the process and analytical development to optimize
production methods and release criteria for tcm8AAV-coNAGLU as a drug substance prior to cGMP
manufacture of the drug product. We will transition production to a suspension platform in order to scale
up production volume consistent with the needs of a commercial product. This portion of the aims of the
parent project were originally to be performed by the NIH BPN biologics contract development and
manufacturing organization (CDMO) during the first and second year of the project, however, changes at
NIH have prevented contracting with a CDMO to begin this process. We have the capacity to perform
non-GMP virus manufacturing runs to optimize production methods and release criteria; develop master
and working cell banks; develop reagent lists and protocols for production; and establish process and
analytical methods development supporting characterization of tcm8AAV-coNAGLU (+/-CpG dep) drug
substance. We did not have this capacity when the parent grant was submitted and did not budget for
this or propose to do these functions at our institution but to have them done by NIH through the CDMO
in accordance with the aims of the grant. In order to reach the milestones of the parent project, the
process and analytical methods for scale up of tcm8AAVco-NAGLU production must be completed by
year 3 in order to allow GMP grade manufacture during year 3 of sufficient quantity of drug substance for
GLP toxicology starting in year 3. In cooperation and agreement with the lead development team
participants from NIH and the NIH consultants, a statement of work for the planned CDMO contract was
assembled. The University of Florida Powell Gene Therapy Center has created a Process and Analytical
Development Group and hired scientists with industry experience in commercial AAV vector production
to allow us to perform the project specific Process and Analytical Development at UF and at
considerably less cost than is anticipated from CDMO bids.
Specific aim 1: Perform non-GMP virus manufacturing runs to optimize production methods and release
criteria; develop master and working cell banks; Develop reagent lists and protocols for production.
Specific Aim 2: Establish process and analytical methods development supporting characterization of
tcmAAV8-coNAGLU/CpGdepcoNAGLU drug substance (DS) and drug product (DP).

Public health relevance
Project Narrative This supplement will enable the continued progress of the parent project to develop an AAV gene therapy product for the treatment of mucopolysaccharidosis type IIIB, a disease for which there is no current treatment. Specifically, this supplement performs the process and analytical development to optimize production methods and release criteria for tcm8AAV-coNAGLU as a drug substance prior to cGMP manufacture of the drug product for transition to toxicology and then clinical studies to treat mucopolysaccharidosis type IIIB.